Novel Models and Biorepository For Early Detection And Therapeutic Intervention Of Pancreatic Cancer

Project Summary
I am a Research Manager in Dr. Surinder Batra’s lab at the University of Nebraska Medical Center (UNMC).
Dr. Batra’s laboratory is engaged in basic and translational research in pancreatic cancer and uses several
genetically engineered mouse models (GEMMs) to study molecular mechanisms, biomarkers, and
therapeutic modalities. My expertise is in providing unique resources to Drs. Hollingsworth, Jain, Ouellette,
Ponnusamy, Singh, and others research on pancreatic cancer (PC). I am also the Comparative Medicine
designated Laboratory Animal Coordinator for supervising Batra Lab’s animal research. My role has been
critical in developing all the GEMMs for PC. Dr. Batra has been working on pancreatic cancer to study the
role of mucin (MUC4, MUC5AC, and MUC16) and non-mucin genes (C1GALT1, PD2, CXCR2, NCOA3, and
NGAL) in disease pathobiology and evaluating their utility for early detection and therapy. Specifically, Dr.
Batra’s laboratory is funded to investigate the molecular mechanism of pancreatic cancer progression and
metastasis, evaluate biomarkers, and test therapeutic agents. This R50 award will support my efforts towards
four significant aspects of Dr. Batra’s research program, funded by P01, two U01s, and several R01 Awards
from NCI. These projects are focused on: a) understanding MUC16 mucin-mediated molecular
mechanisms for pancreatic cancer metastasis; b) investigating the role of truncated O-glycans on
cancer-associated glycoproteins (membrane-tethered mucins and stemness markers); c) develop and
evaluate MUC4- targeted near-infrared (NIR) probes for optical surgical navigation of PC; d) validation
of biomarkers for risk prediction and early diagnosis of Pancreatic Adenocarcinoma; e) examining
mucin-based biomarkers to improve early cancer detection. I am involved in various aspects of the Unit
Director’s research program, including 1) animal model development, 2) experimental therapeutics, and 3)
biomarker research. I have been deeply involved in optimizing the production of in-house generated
therapeutic antibodies using advanced mammalian expression systems and bioreactors (compatible with
GMP scale antibody generations) and assessing their efficacy in pancreatic tumor xenografts. My major focus
has also been developing and maintaining KC and KPC GEMMs of PC and further engineering these lines
for the overexpression/knockout with project-specific genes (MUC4 and MUC16). My biomarker research
involvement includes assays and reagent development, biospecimen processing archiving and distribution,
and data coordination. I have spearheaded efforts to employ innovative approaches for experimental
therapeutics (organoid models, Live cell imaging, antibody efficacy) and biomarker research (Digital Droplet
PCR and Multiplex assays). My continued involvement in PC research under the Unit Director’s supervision
can lead to novel diagnostics approaches and develop innovative antibody modalities for PC treatment.

Public health relevance
Project Narrative Dr. Batra’s research program is focused on understanding the role of tumor-associated genes, particularly mucins, in PC pathobiology and their utility as diagnostic and therapeutic targets. Dr. Batra's lab has established a panel of therapeutic antibodies against mucins and is moving towards testing these antibodies in novel genetically engineered mouse models (GEMM). I am the key player in developing GEMMs, optimizing antibody productions using GMP-grade mammalian expression systems and bioreactors, innovative organoids, managing biospecimens, and employing ingenuity, efficiency, and innovation to further pancreatic cancer research in Dr. Batra’s laboratory.